Behavioral and Molecular Consequences of Tau Pathology in Locus Coeruleus in Prodromal Alzheimer's Disease

PROJECT SUMMARY
Alzheimer’s disease (AD) is the most prevalent form of dementia, affecting 55 million worldwide, and is typified
by extracellular deposits of amyloid-β (Aβ) plaques and intracellular tau neurofibrillary tangles. Numerous clinical
trials designed to alleviate cognitive symptoms by targeting Aβ pathology have failed. However, few studies have
comprehensively examined the earlier, prodromal stages, which are characterized by anxiety, agitation,
depression, and sleep-wake disturbances that significantly disrupt quality of life and ability to remain
independent. The noradrenergic nucleus locus coeruleus (LC) modulates these physiological processes and is
the first region to accumulate hyperphosphorylated ‘pretangle’ tau decades before cognitive deficits and Aβ
plaques appear. It is therefore important to establish whether a causal relationship between LC tau pathology
and prodromal symptoms exists because it can lead to development of therapeutic interventions that relieve
these devastating non-cognitive symptoms and possibly halt disease progression. While catastrophic LC cell
body degeneration occurs in late AD, the earlier prodromal phases are characterized by aberrant tau
accumulation and reductions in LC innervations to projection regions. Moreover, there are suggestions that
surviving LC neurons show compensatory increases in firing accompanied by elevations in forebrain adrenergic
receptors, thus promoting noradrenergic hyperactivity that could underlie the prodromal symptoms. Since most
animal models fail to recapitulate the pathological prodromal feature of hyperphosphorylated tau in the LC, I will
develop a biologically valid mouse model where aberrant forms of tau are exclusively expressed in the LC using
viral vector-mediated strategies. In Aim 1, I will determine if LC tau burden disrupts LC-sensitive behaviors
relevant to prodromal symptoms and exacerbates neuropathology. In Aim 2, I will interrogate the genetic
mechanisms that underlie tau-mediated LC dysregulation and degeneration by using Translating Ribosome
Affinity Purification (TRAP) to selectively isolate the LC transcriptome and RNAscope in situ hybridization to
assess downstream effects on adrenergic receptor gene expression in LC-projecting regions. I hypothesize that
aberrant tau in the LC will cause behavioral abnormalities that are commonly associated with the prodromal
phase of AD and disrupt normal noradrenergic transmission. Successful completion of these aims will reveal
putative molecular mechanistic factors that underlie prodromal symptoms commonly experienced by AD patients
and can yield disease-modifying targets for therapeutic interventions.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is a progressive neurodegenerative disorder, affecting 6.2 million individuals and families in the United States emotionally and financially, with patients suffering from devastating non-cognitive, prodromal symptoms such as anxiety, depression, agitation, and sleep disturbances early in the disease followed by cognitive impairment. With an aging population and the dearth of disease-modifying therapies available, it is imperative to investigate the mechanisms that contribute to early AD. This proposal will test the hypothesis that tau-mediated disruptions in the locus coeruleus-norepinephrine (LC-NE) system underlie the development of prodromal symptoms and uncover molecular alterations associated with LC-NE dysfunctions to develop effective therapeutic targets for AD.